2023 Neuroimmune Communication in Health and Disease Gordon Research Conference and Gordon Research Seminar

Project Summary / Abstract
This proposal is requesting partial support for graduate students, post-doctoral fellows, and junior faculty to
participate in the Gordon Research Seminar and Conference (GRS and GRC) entitled “Neuroimmune
Communication in Health and Disease: Neuroimmunology in Organismic Function: Shared Mechanisms and
Reciprocal Interactions”, which will be held in Ventura, CA on January 21-27, 2023. The overall goal of this
international conference is to increase our understanding of mechanisms that regulate neuroimmune interactions
during homeostasis and neurological disorders. The field of neuroimmunology has evolved considerably over
the past two decades and emerged as one of the fastest moving disciplines in biomedical research.
Neuroimmunology GRC is specifically designed to capture the breadth of the field through cutting-edge sessions
focused on how the neuroimmune system regulates the healthy CNS and peripheral nervous system (PNS) and
underlies pathologic processes during disease. As such, the 2021 program will begin with a keynote session on
the co-evolution of the nervous and immune systems, a paradigm-shifting field that is providing evidence that
these systems began as a single system that each evolved separately in response to exposures to microbes.
The conference will congregate top tier scientists operating at the nexus between these two disciplines, including
faculty and trainee newcomers to this field. Novel concepts pertaining to the complexities of the neuroimmune
interface will be explored and discussed in featured talks and daily poster sessions. An intended strength of this
meeting will be diverse representation of scientists from all over the world and neuroimmunology leaders as
session chairs who will engage young scientists in the field, especially the trainees, to lead the discussions.
The major session themes of Neuroimmune communication in health and disease GRC will capture some
of the most exciting areas of contemporary cutting-edge research in the field, such as the role of
microglia and glia during homeostasis and in neurological diseases, immune effects on brain function,
immunity and neurodegenerative diseases, blood-brain barrier and other barriers' function and
dysfunction, microbiome-CNS communication, infections as triggers of chronic neurodegenerative
disease, and neuroimmunology of the peripheral nervous system. The information gained from this
meeting will inform and advance the field of neuroimmunology through data-driven discussions that
highlight the breadth and depth of the field, and important questions to be addressed. Neuroimmune
mechanisms are involved in all aspects of nervous system health and function, with perturbations
leading to disruption in neural cell function and pathologic processes that cause severe disease. This
GRC will explore important questions regarding the role of neuroimmune interactions as fundamental to
nervous system functions.

Public health relevance
Project Narrative The 2023 Gordon Research Conference on Neuroimmune Communication in Health and Disease: Neuroimmunology in Organismic Function: Shared Mechanisms and Reciprocal Interactions boasts five days of talks that include translational and basic science that are highly relevant to human health. Neurologic diseases are increasingly being recognized as disorders of the neuroimmune system that induce a variety of diseases in the CNS and periphery. The ultimate goal of this conference is to help fulfill the missions of the National Institutes of Health by providing a detailed understanding and stimulating discussions of these complex interactions, which will improve our ability to diagnose, prevent, and treat human diseases of the nervous system, which all include neuroimmune mechanisms and targets.